Health in Our Hands: Building and sustaining student engagement in genomic and environmental health sciences through a community-school partnership (Health in Our Hands)

Contact PD/PI: Bayer, Irene
Project Summary/Abstract
This proposal requests supplemental funds for our current SEPA grant, Health in Our
Hands: Building and sustaining student engagement in genomic and environmental health
sciences through a community-school partnership, 1R25GM132964-01 to expand our
research protocol. Health in Our Hands connects the science classroom to the community to
give youth and adults an understanding of modern concepts in genetics through curricula
designed to meet the Next Generation Science Standards (NGSS). The current project is
creating summative, pre/post assessments for our curriculum to measure impact of student
learning. Teacher partners expressed the need for more assessments to measure student
learning throughout the unit for both formative assessment purposes and requirements to
have more grades measuring student performance throughout the marking period. To
investigate the feasibility, embedded classroom-based assessments were developed for the
first unit on diabetes adapting the Next Generation Science Assessment Group process
(Harris et al) and piloted with teachers and their students. Results indicated that teachers
found value in the assessments and used them in multiple ways.
This supplement will primarily serve to enhance Specific Aims: #1 and #2 of our parent
SEPA: 1) Assess the impact of a coherent set of place-based, technology-rich, NGSS-
aligned science curriculum materials on student genomic and environmental health learning
and interest in STEM careers across middle and high school grades; and 2) Conduct
innovative professional learning experiences bringing together secondary teachers, informal
educators, and community-based experts to support curriculum and mentoring activities by
strengthening our current project through improvements in assessment of the impact of the
curriculum materials on student learning and enhancing teacher data literacy.
The objectives of the new component of the project will: 1) Design, test and analyze a full
set of pre/post and “embedded assessments” (end of learning set assessments) for both of
our middle school curricula; and 2) Build teacher data literacy to understand and use NGSS-
aligned assessments. This proposal is significant as it takes place in predominantly
marginalized Communities of Color experiencing opportunity gaps in state assessments and
success in science overall. Our work with teachers in these schools seeks to address some of
these inequalities by empowering teachers to prepare students in 3-dimensional NGSS
assessment and use data to inform instruction for success in science learning.

Public health relevance
Project Narrative Health in Our Hands connects the science classroom to the community to give youth and adults an understanding of modern scientific ideas in genetics through curricula designed to meet the Next Generation Science Standards (NGSS) (Health in Our Hands (2022,0706) Curriculum). The project, funded 8/14/2019 - 6/31/2024, is led by CREATE for STEM Institute at Michigan State University in partnership with the Health in Our Hands-Flint/Genesee Partners. Using community-inspired project-based learning, students investigate critical community health concerns and use these real-world contexts to appreciate the importance of both genetic and environmental factors in their risk for disease.